PROJECT 1

Project Abstract: U19 Project 1
Dynamic Surveillance and Clinical Support for Control of Xenotransplant-Related Pathogens
The future success of pig-to-human xenotransplantation is dependent on the provision of pathogen-free organs
and robust microbial surveillance post-transplant when human recipients are heavily immunosuppressed.
Decades of pioneering xenotransplant studies in NHP models have yielded a ‘high priority’ list of candidate
zoonotic pathogens that have mostly been removed from pig herds to ensure the xenografts are free from
infection and can thus function post-transplantation without impeding the health of the human
recipient. Advances in metagenomic- and other sequencing–based approaches now facilitate unbiased
approaches to capture the true diversity of viral, bacterial, fungal, and parasitic organisms that could be impacting
transplant outcomes.
NYU has been actively involved in pig-to-human xenotransplants; 5 heart or kidney studies have been completed
in brain-dead (decedent) models, and recently a pig kidney xenotransplant into a living recipient. NYU has also
recently secured industry funding to perform additional pig-to-human decedent xenotransplants comprising 25
heart, kidney, or liver xenografts. Each of the 6 completed studies has relied on screening for the high priority
pathogens in the xenograft recipient using targeted real-time PCR assays for 9 porcine viruses. We intend to
dramatically expand microbial screening approaches through the development and implementation of a dynamic
wet-lab pipeline that is agnostic to microbial genomic makeup. By implementing metagenomic-based
approaches, complemented with targeted and sensitive PCR-based approaches, we will characterize the true
microbial diversity and use that to inform and advance our microbial screening approaches. To achieve these
goals, we will expand our current infectious disease bioinformatic pipeline to identify strain-level human and pig
pathogens and use cloud computing and machine learning to improve and accelerate analyses. As a third aim,
we will expand return of results (RoR) and clinical decision support (CDS) systems to aid in the management of
transplant-related infections in the recipient. Formal reports will include strain-level identifications and treatment
options informed by pharmacogenetic interactions to avoid adverse events.